Training in Advanced Heart Disease Research

The Cedars-Sinai Heart Institute (CSHI) is applying for the first competitive renewal of its Advanced Heart
Disease Research Training Program. The objective of this Institutional Training Program is to build on our initial
success (66% success rate for K awards in our first graduating class) to provide outstanding team-mentored
training in basic biomedical and translational research to six postdoctoral fellows (3 per year x 2 years). The goal
is to provide postdoctoral fellows with the necessary skills to develop independent and productive academic
careers in cardiovascular science. We seek to ensure that all our trainees, be they PhDs, MDs, MD/PhDs or
equivalent, develop an in-depth knowledge of the basic science underpinning clinically relevant problems in
cardiovascular medicine, as well as a comprehensive understanding of rigorous study design, appropriate
methodology and expert technical execution of basic and clinical studies. This not only provides clinical
investigators with the skills they need to properly test hypotheses generated at the basic science level, but also
informs basic scientists about the clinical aspects of disease in order to stimulate clinically relevant state-of-the-
art investigations in the laboratory. Our training program's areas of research focus include Cardiac Biology,
Arrhythmias, Vascular Biology and Atherosclerosis, Regenerative Medicine, Transplant Immunology,
Cardiovascular Imaging, Women's Health, Community Health, Implementation Science, Precision Medicine and
Genetics. The Training Program takes full advantage of the unique strengths of Cedars-Sinai Medical Center
(CSMC), the largest private teaching hospital west of the Mississippi, which has a longstanding commitment to
translational research and to serving the local community. The CSHI houses the largest adult heart transplant
program in the world, performed an NIH-funded first-in-human trial of cardiac-derived stem cell therapy, and has
attracted many NIH-funded basic and translational investigators. Some of these share joint appointments in other
CSMC units, which include the Regenerative Medicine Institute, Biomedical Imaging Research Institute, and the
Departments of Biomedical Sciences, Medicine, and Pathology. Trainees receive an intensive research
experience in a focused area of investigation, augmented by a formal curriculum that includes both basic and
clinical seminars, instruction in grant and manuscript writing, public speaking, biostatistics and ethics. Several
courses are provided by the Department of Biomedical Sciences, the CSMC Clinical Scholars Program, and a
multi-campus NIH CTSA-supported Center for Translational Science Institute (CTSI, includes CSMC, UCLA,
Harbor-UCLA, and Charles Drew University). The CTSI provides our trainees with privileged access to project
seed funds, additional courses in clinical research design, and tools for conducting the entire range of studies
from bench to bedside to community. In summary, we have designed a program that provides in-depth training
in critical areas of cardiovascular science within an environment that champions translational research and
clinical excellence.

Public health relevance
PROJECT NARRATIVE The Cedars-Sinai Heart Institute is renewing its Institutional Training Grant for its Advanced Heart Disease Research Training Program. The objective of the program is to provide outstanding team-mentored training in basic biomedical and translational research to both PhDs and MD-scientists in order to provide them with the necessary skills to develop independent and productive academic careers in cardiovascular science. These future leaders of medicine will be well-equipped to develop new, more effective treatments for diseases of the heart and blood vessels such as heart attack, heart failure, high blood pressure and sudden death.